NHGRI Research Training and Career Development Annual Meeting

Summary
The National Human Genome Research Institute (NHGRI) provides support for trainees from
the undergraduate to the post-doctoral level in the fields of genome sciences, medicine and
ethical, legal and social implications. The annual Research Training and Career Development
meeting is a venue for NHGRI trainees to present their research and learn about other research
and programs, to network and begin to develop collaborations with other trainees and faculty,
and gain experience of attending professional scientific conferences (this will be the first
professional meeting for some trainees). Duke University was selected to be the coordinating
center for the annual training meeting (#1R13HG011814-01). Duke will provide continued
support for this excellent annual event for trainees and strive to enhance the impact, learning
efficiency and networking opportunities with new and innovative technologies to address the
changing landscape, in part brought on by COVID19. This administrative supplemental request
will provide travel support for advisors to attend the meeting and for trainees that do not have
travel funds available through their award (Fellowship awardees)

Public health relevance
Public Health Relevance The purpose of this administrative supplement is to provide travel support for advisors and trainees to attend the annual Research Training and Career Development meeting that are not part of program that otherwise would cover the costs of attending the meeting. The supplement aligns with the aims of the parent award to coordinate and carry out the annual meeting and other activities for trainees. The success of this proposal will help maximize attendee and facilitate trainee’s development and education.